Core--Coordination

The coordination core has 5 functions: 1. Provide structure and facilitate communication among the investigators in Projects 1 to 4. This communication will take place during weekly meetings with Individual Project Leaders and their staff, and quarterly meetings with the entire Program Project investigators. The purpose of these meetings is to apprise the investigators of the progress of the individual projects and to assess for problems that may occur in technical or organizational aspects of the work. 2. Patient recruitment. The Study Coordinator will be a member of the Administrative Core team and will work directly with the rheumatologists and nephrologists at The Ohio State University and in the collaborating Centers to assist them in identifying and enrolling study patients. 3. Distribution of patient samples obtained from Project 4 to each of the Project laboratories. The Study Coordinator, Working with the Research Assistant in Project 4, will ensure timely delivery of the blood and urine specimens, and under the proper preservation conditions. The initial separation of the blood samples, prior to their delivery to the individual Project laboratories, will also be accomplished by this group. 4. Data management and data analysis. This aspect of the Core function is under the direction of Dr. Nagaraja working in collaboration with Drs. Lin and Gassman. 5. Coordinate the Internal Review Committee's periodic evaluation of the progress of the Program Project. The Internal Review Committee consists of 5 distinguished scientists of The Ohio State University College of Medicine. Their identifies, special interests, and a role in the Program Project are described in Core. The Internal Review Committee should help maintain rigor and appropriate pace for the Program Project.